Deciphering the mechanism of colibactin-induced DNA damage through quantitative and biochemical approaches

Project Summary:
Evidence for the human gut microbiota playing a significant role in health and disease is steadily growing. A
notable example of this is the association of certain commensal strains of E. coli with colorectal cancer (CRC),
the second leading cause of cancer deaths. >60% of CRC patients are home to E. coli possessing the clb
biosynthetic gene cluster (clb+) which encodes for a genotoxic, natural product named colibactin. Cells exposed
to colibactin-producing bacteria are known to undergo G2/M cell cycle arrest, senescence, and megalocytosis
and possess DNA double-strand breaks (DSBs), interstrand crosslinks (ICLs), and chromosomal aberrations.
For these reasons, many speculate that colibactin is the chemical mediator for these processes and that clb+ E.
coli play a vital role in CRC; however, determining the chemical mechanism behind colibactin’s genotoxicity has
been difficult because it has never been isolated. Instead, the structure and bioactivity of colibactin has been
slowly revealed by studying its biosynthesis and DNA-damaging properties. These studies have revealed that
colibactin is a ‘pseudo-dimeric’ crosslinking agent that produces ICLs in vitro and in cells. Attempts to isolate the
ICL lead to the discovery of two DNA monoadducts, which each correspond to one-half of the original crosslink.
This proposal seeks to decipher a chemical mechanism for colibactin’s genotoxicity by 1) quantifying colibactin-
DNA adducts and correlating their levels to established clb+ E. coli phenotypes in vitro and in vivo and 2)
determining colibactin’s sequence specificity and structure when bound to DNA. Successful completion of these
aims will deliver novel methods for specifically measuring colibactin-DNA damage and potential colibactin
biomarkers that could be applied to cancer surveillance and prevention. Additionally, this work will identify
colibactin’s binding motif, which could be applied to identifying target genes within humans, and determine a
structural explanation for how colibactin damages and perturbs DNA. Ultimately, this work will provide
quantitative and mechanistic evidence for colibactin’s genotoxicity and a heightened understanding of the role
clb+ E. coli plays in the pathogenesis of cancer.

Public health relevance
Project Narrative: Colorectal cancer (CRC) is the second leading cause of cancer death in the United States and is associated with human gut bacteria that produce the genotoxic molecule colibactin. A robust, chemical model for how colibactin damage relates to overall genotoxicity and cancer-associated phenotypes could help produce novel screening techniques and therapeutic interventions. The proposed research aims to construct this model by developing colibactin-specific biomarkers of DNA damage and unraveling the chemical interactions between colibactin and DNA.